Effects of general anesthetics on mitochondrial cellular distribution

Project Summary:
The neuron is one of the highest energy-consuming cells within the body. It requires energy to
maintain complex electrical gradients for neuron activation and signal transduction via synaptic
vesicle release. The mitochondria are critical to efficiently create energy and their location within
the cell is tightly regulated through the use of motor protein complexes kinesin (anterograde)
and dynein (retrograde). General anesthetics have been shown to bind to kinesin motor proteins
and decrease their processivity. However, the effect of that binding on cellular machinery,
energy homeostasis and anesthetic sensitivity has not been studied.
This project explores the affect general anesthetics have on mitochondrial location, and by
extension energy, using both the zebrafish in vivo model organism and primary neural cell
culture. I define mitochondrial movement alterations when exposed to different anesthetics.
Next, I define zebrafish larvae and neural cells within two mitochondrial transport, kif5Aa and
actr10, as well as how that movement is altered in response to different anesthetics. Finally, I
will determine how changing the mitochondrial distribution within neurons affects whole
organism behavior by testing for changes in sensitivity to anesthetics within zebrafish larvae.
Completing this project will enhance my skills in neurobiology, mitochondrial biology, advanced
statistics and programming. With these skills I will be able to create a unique niche within the
field of anesthesia. This project will also give me to preliminary data to launch as an
independent investigator and write an R01.

Public health relevance
Project Narrative: The ability to regulate and efficiently use energy is required for neuron signaling within the brain. The neuron targets mitochondria to areas of high energy need through the use of motor proteins, some of which are bound by general anesthetics. This project seeks to define the consequence of that binding on alterations in mitochondrial density within subcellar regions of the neuron and on changes in behavioral responses.